Overcoming the hurdles to successful CAR T cell therapy for a functional HIV cure

Project Summary/Abstract
This proposal seeks the necessary funding to facilitate the career transition of Dr. Daniel Claiborne to an
independent academic scientist. The original aims brought forth in this proposal build upon the basic HIV
virology, immunology, and pathogen-host interaction expertise of the candidate and leverage these skills
towards translational efforts in a small animal model aimed at achieving a functional HIV cure. Furthermore,
the career development plan outlines a path towards acquiring valuable skills necessary for the execution of
this proposal as well as the transition to independence. Finally, the data generated from the successful
execution of these experiments will yield the preliminary data to apply for R01-level funding.
The human immunodeficiency virus (HIV) promptly subverts the host cellular immune response through rapid
viral escape and high antigen loads leading to chronic immune activation and T cell dysfunction. Combination
antiretroviral therapy (ART) has drastically reduced the morbidity and mortality of HIV infection, but must be
taken indefinitely as HIV persists in long-lived stable reservoirs and thus presents a significant public health
burden. One approach to purging the viral reservoir, termed “shock and kill”, relies on latency reversing agents
(LRAs) to reactivate latently infected cells such that they can be cleared by the immune system. However,
clinical trials testing LRAs have achieved little success, perhaps due to the dysfunction of the natural cellular
immune response. Genetic engineering modalities may offer an attractive alternative to intrinsic immunity.
Chimeric antigen receptor (CAR) T cells re-engineered to target HIV using the CD4 ectodomain (CD4-CAR)
represent an escape-resistant “kill” mechanism demonstrated to have enhanced cytotoxic function. Therefore,
we hypothesized that CD4-CAR T cells would be a promising intervention capable of suppressing HIV
replication and effectively targeting the viral reservoir.
To rapidly test and optimize our approach, we made use of the BLT humanized mouse model of HIV infection.
Our preliminary results demonstrate that CD4-CAR T cells respond robustly to antigen, expand up to 1000-fold
in vivo, and significantly protect HIV-infected BLT mice from rapid CD4+ T cell loss. Furthermore, we improved
the expansion potential and cytotoxic function of CD4-CAR T cells, and were able to protect CD4-CAR T cells
from HIV infection. However, despite their ability to enhance viral suppression with ART, CAR T cell therapy
alone was unable to durably suppress viremia in BLT mice. We propose to address this deficit in the following
specific aims: 1) Determine the effect of viral replication capacity on CAR T cell efficacy, 2) map the ontogeny
of exhausted CAR T cells in vivo, and 3) interrogate the role of the innate immune system in modulating CAR T
cell function. Completion of these aims will enhance our understanding of the factors contributing to T cell
dysfunction in chronic viral infections, with the hope of translating these findings towards a functional HIV cure.

Public health relevance
Project Narrative The invention of antiretroviral drugs capable of fully suppressing HIV replication in infected individuals has drastically reduced the morbidity and mortality associated with this viral infection. However, HIV persists as a stable reservoir in long-lived memory T cells, requiring lifelong treatment of infected individuals. Genetic engineering approaches, including chimeric antigen receptor T cells reengineered to target HIV instead of malignancies, offer a powerful method to confer anti-HIV immunity capable of suppressing viral loads without antiretroviral drugs, and represent promising candidates for a functional HIV cure.